Dynamic embedding time series models in functional brain imaging

Project Summary
We will develop new large-scale dynamic embedding models of network data with a focus on dynamic connec-
tivity matrices from non-stationary multivariate time series obtained from human functional magnetic resonance
images (fMRI). We propose to model brain networks as 2D curved surfaces, where the surface geodesics give
connectivity information. Our approach will bypass the use of parcellations and more accurately evaluate the
evolutionary dynamics of functional brain networks at the voxel level.
We propose to build dynamically changing functional brain networks from a dataset with 1206 subjects from
the Human Connectome Project (HCP) database containing T1-weighted magnetic resonance images (MRI),
diffusion MRI (dMRI) and task and resting-state functional MRI (fMRI). MRI and dMRI will be used in conjunction
with fMRI in building more reﬁned dynamic connectivity models. Using 243 pairs of twins in the HCP database, we
will determine network phenotypes speciﬁc to behavior, cognition and their genetic associations. This study will
provide the research community with the brain network heritability maps and as well as a versatile open-source
toolbox of algorithms for modeling and visualizing dynamically changing large-scale brain networks.

Public health relevance
Project Narrative The goal of this study is to develop new statistical methods, algorithms and open-source software for building large-scale embedding models of brain networks using fMRI of 1206 subjects available from the publicly available Human Connectome Project database. The proposed models and algorithms will be used to establish the base- line map for the genetic inﬂuences on brain networks at the voxel level. Considering recent surge of interests in dynamic brain network phenotypes in relation to cognition, behavior and genetics, such detailed heritability maps will be highly useful as a baseline for future studies.